Probing the role of epigenomics in Brca1-deficient mammary tumors.

Abstract/Project Summary
Every year, breast cancer kills more than a half-million women worldwide. Monumental efforts have made an
impact toward understanding primary disease and the development of targeted therapies. Yet, these therapies
still fail many women initially, and others relapse with therapy-resistant disease. Thus, we must focus on
developing better tools to predict disease susceptibility in those at higher risk, while augmenting the search for
molecularly based strategies to prevent breast cancer.
More specifically, mutations in the BRCA1 genes, and their consequent loss of function, are the most clinically
relevant genomic alterations that increase the susceptibility of individuals to breast cancer. Still, not all women
with BRCA1 mutations will develop breast cancer. Thus, we need a clear picture of the mechanisms that
govern cancer susceptibility. Our main goal is to define how the epigenome alters the development of
Brca-1 deficient mammary tumors.
We previously demonstrated that the mammary epithelium epigenome and specific chromatin remodeling
factors play a role in oncogenesis progression. Now, we hypothesize that the epigenome similarly contributes
to the development of BRCA1 mutant breast tumors. We will use innovative models of mammary oncogenesis
to specifically dissect epigenetic mechanisms that influence the development of Brca1-deficient mammary
tumors.
By investigating the effects of a specific epigenetic regulator (BPTF) and a global epigenomic program
(pregnancy) on mammary tumor progression, we may also identify prognostic biomarkers that will enable us to
identify women who will benefit from therapy. Ultimately, we hope to validate our hypotheses pre-clinically
using normal and malignant human breast organoid cultures, to aid the development of strategies that will be
useful as primary prevention in humans.

Public health relevance
Project Narrative One in eight women will develop breast cancer over the course of her lifetime, and half of those women will succumb to the disease. Genetic predispositions, like mutations in the BRCA1 gene, increase the risk of developing breast cancer by over 50%, but it is largely unclear what determines whether cancer will in fact develop in a particular patient. Our previous work identified a role for epigenetic alterations in modulating to breast cancer, and we now aim to determine how alterations to the epigenome affect the development of Brca1-deficient mammary tumors, a strategy that will help to identify molecular pathways as potential strategies to block development of BRCA1-deficient breast cancer.